Community Health Worker-Led Church-Based Intervention for Eliminating Cardiovascular Health Disparities in African Americans

Flor Alvarado, Diversity Supplement
Project Summary
The “Community Health Worker-Led Church-Based Intervention for Eliminating Cardiovascular Health
Disparities in African Americans (CHERISH)” study is a cluster randomized trial that will test whether a
community health worker (CHW)-led and church-based multifaceted strategy for implementing 2019
ACC/AHA Guidelines on the Primary Prevention of cardiovascular disease (CVD) can reduce
cardiovascular health disparities among African Americans residing in New Orleans, Louisiana. Extensive
research highlights the impact of social determinants of health (SDH) on cardiovascular health, and
particularly suggest that individual-level determinants may not fully account for variation in CVD-related
outcomes. Areas with socioeconomic deprivation have been linked to greater mortality and CVD related
outcomes, whereas neighborhood physical and social environments have also been tied to CVD risk,
independent of individual level factors. However, there has been limited research evaluating the
associations between neighborhood SDH and earlier outcomes that may influence cardiovascular health
including: regular use of routine preventative care or prescribed medications, confidence in actively
engaging in medical care, or perceptions related to acceptability, appropriateness, and perceived
feasibility of participating in lifestyle and pharmaceutical interventions. Understanding how these
outcomes are influenced by neighborhood factors is critical. To this end, the objective of this ancillary
study, is to use a mixed-methods approach to evaluate the relationships between neighborhood-level
SDH to these upstream health-related beliefs and behaviors among African Americans at risk for CVD
residing in in New Orleans, LA. These critical assessments of neighborhood-level SDH in the target
population will help inform the intervention and provide further context for the interpretation of
outcomes in the parent study.

Public health relevance
Flor Alvarado, Diversity Supplement Project Narrative The objective of this PA-21-071 Administrative Supplement is to leverage the planning phase of the “Community Health Worker-Led (CHW) Church-Based Intervention for Eliminating Cardiovascular Health Disparities in African Americans” study to conduct critical assessments of neighborhood-level social determinants of health (SDH) in the target population, to help inform the intervention and provide further context for the interpretation of outcomes in the parent study. This study is composed of both quantitative and qualitative assessments to evaluate the relationships between neighborhood SDH and health-related beliefs and behaviors impacting cardiovascular health.